The role of the COP9 signalosome in distal nephron remodeling

Abstract
DCT remodeling has been associated with human diseases, changes in dietary salt intake, and drug
administration. The disease familial hyperkalemic hypertension (FHHt) and diuretic resistance cause
hypertrophy and hyperplasia; whereas, Gitelman and EAST syndromes lead to DCT atrophy. Yet despite its
clinical significance, the cellular and molecular basis for this plasticity is unclear. The DCT comprises two
subsegments, the early DCT1 the late DCT2. Knepper and colleagues, using single cell transcriptomics, recently
identified a rare proliferative cell population within the DCT1, which they suggested may be responsible for the
DCT's unique plasticity. Preliminary data from our lab showed that dietary potassium deficiency increased the
percent of these proliferative cells in the DCT and caused DCT hypertrophy, especially along the DCT1.
Furthermore, this work showed the proliferative DCT cell type to have lower levels of transport protein transcripts
and higher levels of proliferative transcripts, suggesting that DCT1 cells dedifferentiate into a more proliferative
state. Cullin-RING-ligases (CRLs) are a family of E3 ubiquitin ligases that mediate regulated degradation of
proteins and are involved in many cellular functions important for cell maintenance and elimination of unwanted
proteins. CRLs were recently discovered to regulate blood pressure via proteasomal degradation of with-no-
lysine kinases (WNKs). Cullin 3 (CUL3) is the critical component of CRLs, which add ubiquitin moieties targeting
proteins for proteasomal degradation. Mutations in CUL3 cause the disease FHHt. All CRLs are regulated by
the COP9 signalosome (CSN), which interacts with the CRL and turns off ubiquitin ligase activity. Disease-
causing CUL3 mutations inhibit the ability of CUL3 to interact with the CSN and therefore leave CUL3
hyperactivated. To investigate the role of impaired CSN-CUL3 interaction in human disease, we inactivated the
CSN by deleting Jab1 (the key CSN catalytic subunit) along the entire nephron. Despite the fact that both CUL3
and the CSN are expressed all along the nephron, these mice (KS-Jab1-/-) showed remodeling only along the
distal nephron, with shortening of the DCT and a large reduction in DCT1-specific proteins. Here, we plan to test
our hypothesis that CSN dysfunction causes dedifferentiation of DCT1 cells leading to DCT remodeling using
recent technological advances and new mouse models that allow us to study DCT remodeling at the protein and
transcript level in unprecedented detail. We have utilized fluorescence-activated nucleus sorting (FANS) of DCT-
specific INTACT (Isolation of Nuclei Tagged in specific Cell Types) reporter mice, which have inducible nuclear
GFP expression to greatly enrich for DCT cells. We pair this with single nucleus RNA sequencing (snRNA-seq)
that generates remarkably granular data about DCT cell populations. The proposed experiments with Jab1-/-
mice will shine a light on the plasticity of the DCT, helping to uncover the mechanisms for DCT remodeling
caused by CSN dysfunction. This will reveal valuable information that could have clinical and biological
importance in advancing therapies in cases where the DCT remodels.

Public health relevance
Project Narrative Remodeling of the distal convoluted tubule (DCT) in the kidney has been associated with human diseases, changes in dietary salt intake, and drug administration. Yet despite its clinical significance, the cellular and molecular basis for this plasticity is unclear. The proposed research will use state-of-the-art mouse models and RNA sequencing techniques to determine how COP9 signalosome (CSN) dysfunction causes remodeling of the DCT, which will help uncover the molecular mechanisms behind nephron segment remodeling.